Relationship between inner ear function, amyloid precursor protein and CNS pathology

Clinical studies have suggested a link between the loss of sensory function in the inner ear and the development of Alzheimer’s disease. The biological basis of this association is not clear. Neurodegeneration that occurs in Alzheimer’s disease (AD) appears to be caused by aberrant processing and clustering of protein fragments derived from amyloid precursor protein (APP) and the microtubule-associated protein Tau. Consistent with this notion, certain identified mutations in APP and Tau are known to greatly increase the risk of developing AD. The projects outlined here are partly motivated by our observation that high levels of APP and Tau are also present in the hair cells and afferent neurons of the cochlea and vestibular organs, raising the possibility that these proteins might contribute to degeneration in the aging inner ear. However, it is equally possible that inner ear dysfunction is linked to AD because the loss of sensory input from the aging inner ear increases the likelihood of CNS degeneration and dementia. Experiments proposed here will use established mouse models of Alzheimer’s disease and engineered deafness to address these issues. In Aim 1, we will determine whether b-amyloid and Tau deposition and subsequent degeneration occurs in the inner ear. Experiments in Aim 2 will test whether disruption of inner ear function leads to increased CNS neuropathology in a mouse model of Alzheimer’s disease. To our knowledge, these will be the first studies to directly examine the potential relationship between inner ear function and amyloid-related CNS pathology. The outcomes may reveal a role for APP in degeneration of the inner ear, or indicate that input from the ear affects amyloid deposition in the CNS. A more complete understanding of the link between inner ear function and Alzheimer’s disease may also lead to novel diagnostics for the detection of early stage AD in humans.

Public health relevance
Clinical studies suggest that hearing and vestibular deficits are associated with the development of Alzheimer’s disease. We have shown that amyloid precursor protein (APP - an important mediator of neurodegeneration in Alzheimer’s disease) is abundantly expressed in the inner ear. Proposed projects will examine the possible pathological role of APP in the cochlea and vestibular organs, and also examine whether loss of sensory function in the ear leads to early degeneration in the central nervous system.